Kidney-resident memory CD8+ T cells promote hypertension and memorize salt sensitivity.

Kidney-resident memory CD8+ T cells promote hypertension and memorize salt sensitivity.
Abstract:
An estimated 116 million adult Americans suffer from hypertension, a leading contributor to
cardiovascular mortality in the United States. Despite the development of many classes of
antihypertensive drugs, only 23.9 million patients obtain effective blood pressure control, implying gaps
in our understanding of the complex pathogenesis of hypertension. In recent years, immune cells,
specifically CD8+ T cells (CD8Ts), have been implicated in the onset of hypertension. Studies from our
group tied CD8Ts directly to aberrant sodium retention within the kidney, beginning with the activation
of CD8Ts via purinergic receptor P2X7-mediated calcium influx, resulting in increased production of
IFNγ, which enhances the direct interaction between CD8Ts and distal renal tubules, leading to sodium
chloride cotransporter (NCC)-mediated excessive salt retention, thereby promoting hypertension. An
intriguing discovery in our study is that although antihypertensive treatment temporarily lowered BP in
hypertensive animals, it failed to disrupt T cell residency in the kidneys, and salt-sensitive hypertension
resurges after ceasing treatment. These findings raise the possibility that a continued adaptive immune
response to an initial BP elevation may contribute to the ‘memory of salt sensitivity’ within the kidneys.
We hypothesize that the P2X7-TGFβ axis establishes long-term residency of kidney CD8Trms, which
exacerbates salt retention and instills “salt memory” of hypertension. First, we aim to determine the
critical role of TGFβ signaling in forming kidney-CD8Trms and their impact on the progression of salt-
sensitive hypertension. Next, we will define the impact of kidney-CD8Trms on ‘salt memory’ in the
kidney and the subsequent recurrence of salt-sensitive hypertension. By establishing long-term CD8T
residence through kidney Trms, this study will provide a mechanism behind the longevity of
hypertension and identify a resident immune cell population in the kidney that confers the ‘salt
memory’ contributing to the progression and recurrence of hypertension.

Public health relevance
High blood pressure, a leading cause of heart disease and the primary cause of death in the world lacks a complete understanding of its root causes and mechanisms of often-seen recurrence. Recent studies have indicated that the immune system may contribute to this rise in blood pressure, with our lab revealing immune cells interacting with kidney cells, leading to increased salt and water retention. This study aims to identify factors triggering immune cell residence in the kidney and understand their role in long-term blood pressure elevation and recurrence, offering insights for improving medications and ultimately aspiring toward a cure for hypertension.